IGF:OT:IGF Production and Distribution of Investigational Ghrelin Vaccines--Ghrelin Vaccine Against Rat Hormone. Task Order 4 HHSN275201500006I/HHSN27500004). 9/21/2018 to 9/20/2019.

The purpose of this Task Order is to synthesize ghrelin vaccines against rat ghrelin hormone, evaluate effectiveness and selectivity of vaccine treatment from plasma samples, ship vaccines to NIH-supported intramural and/or extramural investigators, designated by the NIAAA, for testing against alcohol-seeking behaviors and provide supporting data for vaccine synthesis methods and efficacy.